Mechanism and Regulation of Axonemal Dynein Arm Assembly in Motile Ciliated Epithelial Cells

Motile cilia beat rhythmically to propel cell movement or drive extracellular fluid flow. The functional importance
of cilia motility in human health is highlighted by primary ciliary dyskinesia (PCD), a genetic disease caused by
cilia motility defects. Patients with PCD display left-right asymmetry defect, reduced fertility and progressive lung
disease. Currently there is no specific therapy for PCD and management of symptoms has been the main
approach. The dynein arms that power cilia motility comprise multiple components that are pre-assembled in the
cytosol and many genes associated with PCD encode components of these dynein arms. Intriguingly, however,
a separate group includes proteins that reside in the cytosol and appear to be involved in the assembly of dynein
arm subunits and they are called dynein arm assembly factors (DNAAFs). Interestingly, multiple DNAAFs are
localized in droplet shaped cytosolic foci. However, the precise function of these foci and the precise molecular
function of most DNAAFs remain poorly understood. In addition to the assembly of protein components, how
mRNAs and the translation machinery are coordinated to supply dynein arm components stoichiometrically is
also largely unknown. Based on extensive preliminary and published data, our central hypothesis is that the co-
chaperone proteins Pontin and Reptin are core components of a novel membraneless cytosolic assemblage
distinct from droplets formed through LLPS; they function to coordinate the translation, folding and assembly of
axonemal dynein arm components and prevent aggregate formation. In this project, we will combine zebrafish
genetics, mouse genetics and cultured tracheal cells to test our central hypothesis. We propose two specific
aims to achieve this goal. In the first aim, we will dissect the molecular and cellular function of Pontin-Reptin foci
in discrete steps in dynein arm assembly. In the second aim, we will characterize Pontin-Reptin foci and
investigate the mechanism of foci formation. Successful completion of this project will not only provide a
molecular framework for dynein arm assembly and the etiology of PCD, but also lay the foundation for future
investigation into the regulation, and possible intervention, of dynein arm assembly and cilia motility under
diverse physiological and disease conditions.

Public health relevance
Cilia motility is essential for airway clearance and is powered by a large motor called the dynein arm. Defective dynein arm is responsible for primary ciliary dyskinesia (PCD), a genetic disease characterized by mucus impaction, recurrent sinopulmonary infections and accelerated decline of lung function. This project focuses on understanding the function and regulation of the co-chaperones Pontin and Reptin in building dynein arms, the powerhouse of cilia motility, and is highly relevant to PCD.